PEDIATRIC HIV LATE OUTCOMES PROTOCOL

This longitudinal study will follow infants, children and adolescents enrolled in perinatal and pediatric ACTG clinical trials in order to monitor late consequences of therapy including long-term survival and quality of life; benefits, toxicities or other adverse outcomes from use of antiretroviral, immune and vaccine-based therapies geared to both prevent the progression of HIV and prolong the survival of HIV-infected individuals.